Administrative Resource for Biodefense Proteomics Research Programs

This center supports the Proteomic Resource Centers by handling administrative matters as well as designing, developing and maintaining a publicly available website. The website will contain listings of all the data, reagents and protocols generated by the Proteomics Resource Centers for use by the general scientific community.